Role of TRIM46 in neuronal polarity in vivo

PROJECT SUMMARY.
From movement to memory, the complex and wide-ranging tasks performed by the nervous system depend on
the polarization of billions of neurons into two functionally distinct subcellular compartments: dendrites, which
receive most of the input into the neuron, and the axon, which transmits information to other cells in the form of
an action potential. Two powerful contributors to neuronal polarity are 1) the axon initial segment (AIS), a domain
at the beginning of the axon that initiates action potentials, and 2) microtubules (MTs), cytoskeletal filaments
involved in axon outgrowth and cargo trafficking1,2. Disrupting either of these impairs the other and causes broad
downstream defects in neuronal polarity and function3–6, suggesting that the interplay between these structures
is a key regulator of neuronal polarity. Intriguingly, MTs within the AIS form bundles, called “fascicles”, that are
rarely observed outside the AIS7,8. This unique organization supports the idea that the AIS and MTs work together
to control neuronal polarity. Therefore, investigating MT fasciculation could unlock new insights into how neurons
establish and maintain polarity, as well as how that process might go awry in neurodevelopmental and
neurodegenerative disorders. Though AIS MT fasciculation was first observed over 50 years ago7,8, little
progress has been made in determining its function, largely because a lack of candidates for the driver of MT
fasciculation made loss-of-function studies impossible. However, a recent breakthrough occurred with the
discovery of the protein Tripartite Motif Containing 46 (TRIM46) at the AIS9. TRIM46 localizes to AIS MTs, and
TRIM46-deficient cultured neurons lack AIS MT fasciculation9,10. They also exhibit impaired AIS formation and a
range of defects in axonal outgrowth, protein distribution, and MT orientation, suggesting that TRIM46 is required
for both AIS MT fasciculation and neuronal polarity more broadly9. However, these exciting claims are based on
TRIM46 knockdown by shRNA, mostly in cultured neurons, so the observed defects could be attributed to shRNA
toxicity or the artificial culture environment. No work has been done to investigate TRIM46 knockout in vivo. This
project will leverage the Rasband lab’s extensive experience with the in vivo study of the AIS to fill this gap. The
objective of this proposal is to use TRIM46 knockout mice to determine the role of TRIM46 in the nervous system
and test the specific hypothesis that TRIM46 is required for AIS MT fasciculation and neuronal polarity in vivo.
The proposed experiments will use immunostaining and high-resolution microscopy methods to determine the
consequences of TRIM46 knockout from neuronal ultrastructure to behavior and in the contexts of development
and injury. Aim 1 will determine the role of TRIM46 in AIS formation, ultrastructure, and MT fasciculation. Aim 2
will determine the role of TRIM46 in neuronal morphological, molecular, and MT polarity. Aim 3 will determine
the consequences of TRIM46 knockout on neuronal migration, axon regeneration, and behavior. Completion of
this project will reveal the function of TRIM46 at the convergence of the AIS and MTs from which neuronal
polarity emerges.

Public health relevance
PROJECT NARRATIVE. A healthy nervous system requires the polarization of neurons into structurally and functionally distinct compartments. Both the axon initial segment and the microtubule cytoskeleton play key roles in neuronal polarity, and disruption of either causes profound defects in neuronal structure and function. This project seeks to understand how the axon initial segment and microtubules interact to establish and maintain neuronal polarity.